Novel VP30-host Interactions that Negatively Regulate Ebola Virus Infection

Project Summary/Abstract
The filoviruses, Ebola and Marburg viruses (EBOV and MARV), are emerging, negative-strand RNA viruses
associated with outbreaks of severe viral hemorrhagic fever. The virulence and emerging nature of these
zoonotic pathogens makes them a significant threat to human health, potential agents of bioterrorism, and
NIAID category A priority pathogens. The overall goal of the parent R01 application is to characterize EBOV
VP30 (eVP30), a key viral protein that facilitates viral transcription, and its interactions with host factors. This
supplement request in response to PA-21-071 - Research Supplements to Promote Diversity in Health-Related
Research (Admin Supp - Clinical Trial Not Allowed) will support the training and career development of trainee
currently enrolled in a medical student training program to develop her career as a physician scientist.
Scientific research program, which extends protein-protein interaction and post translational modification
studies will map the ubiquitination of filoviral proteins. These proposed efforts will enhance our understanding
of filoviral-host interactions and provide an opportunity for career development.

Public health relevance
Project Narrative Pathogenic Ebola and Marburg viruses cause rare but deadly outbreaks among human populations. The current studies are important as they will identify novel host targets that are important for viral replication and define broad spectrum targets to develop therapy and provide critical training opportunities to a trainee that will promote diversity in health-related research.